Analytical Pharmacology

Abstract Shared Resource 02: Analytical Pharmacology (AP-SR)
The Analytical Pharmacology Shared Resource (AP-SR) provides comprehensive analytical and consultative
services to COHCCC Members in a GLP-compliant environment. The AP-SR assists with the design and
implementation of pharmacokinetic, pharmacodynamic, and biomarker correlative studies for clinical and
preclinical investigations of small molecules and biologic agents. The AP-SR also provides GLP-compliant
quality control release testing of CC manufactured cell therapies.
Specific Aims of AP-SR:
Aim 1. Provide support for clinical investigators and trainees requiring expertise in pharmacokinetics,
pharmacodynamics, and molecular correlative laboratory studies.
Aim 2. Facilitate preclinical cancer-focused research to support basic, translational, and population
scientists and trainees who require analytical services.
Aim 3. Perform GLP-compliant quality control (QC) in-process and final product release testing and
provide correlative analyses in support of the COHCCC Cellular Therapy Program.
Services include: 1) initial consultation on research projects; 2) study design and protocol review, including
collaboration with biostatisticians; 3) development, implementation, and validation of analytical methods;
4) sample acquisition, tracking, and storage; 5) sample analysis (e.g., LC-MS/MS, ICP-MS, HPLC, Luminex,
ELISA, FACS, and qPCR); 6) QC final product release testing (e.g., mycoplasma, endotoxin, cell potency and
identity, cell counting and viability, cell specific lysis); 7) pharmacokinetic programming and data analysis; and
8) participation in collaborative writing for manuscripts and grant proposals. The AP-SR is directed by Dr. Timothy
Synold and is supported by 13 FTEs.
Members Utilization by %Revenue 2017–21: 93.8 Total (4.3 MCBC, 25.3 DCT, 22.2 CI, 35.8 HM, 6.2 CCPS)
Publications by Members: 44, 12 with Impact Factor >10
Grants Supported: 52 Total (9 CIRM, 1 DoD, 2 LLS, 20 NCI of 34 NIH ( 20R01, 4U01))